TO PROVIDE MARKETING AND OUTREACH FOR THE NIAAA SBIR/STTR PROGRAM TO HELP COMMUNICATE THE OBJECTIVES OF THE PROGRAM.

TO PROVIDE MARKETING AND OUTREACH FOR THE NIAAA SBIR/STTR PROGRAM TO HELP COMMUNICATE THE OBJECTIVES OF THE PROGRAM.